Adaptive resistance to HIF1a inhibition in hypoxia

Project Summary Patients with advanced and metastatic cancer have limited treatment options and face grim outcomes. There is an urgent need for novel and effective treatments. Hypoxia is a universal pathological feature of solid tumors. Hypoxic tumor cells acquire metastatic and lethal phenotypes primarily through the activities of hypoxia- inducible factor 1 alpha (HIF1α). Therefore, HIF1α is considered as a promising therapeutic target. To date, while several HIF1α inhibitors have been discovered and validated in preclinical studies, the clinical translations of these agents have been less successful. The robust antitumor effects seen in preclinical models are not observed in clinical trials. The reasons for the poor clinical efficacy are unclear. Thus, the long-term goal of this proposal is to understand how tumor cells adaptively respond and develop resistance to HIF1α inhibition, and harness this knowledge to translate HIF1α inhibitors into clinically effective and sustainable treatments. In preliminary studies, we specifically inhibited HIF1α using stable shRNA in multiple human tumor cell lines. We found that although tumor cells were initially sensitive to the antitumor activities of HIF1α inhibition, they quickly developed resistance in hypoxia in vitro and in xenografts in vivo even though HIF1α remained inhibited. Mechanistically, we observed that tumor cells adaptively responded to HIF1α inhibition by increasing the stability of oncogenic protein ID1 in hypoxia, and we found that silencing ID1 restored sensitivity to HIF1α inhibition, while overexpressing ID1 conferred resistance. In this proposal, we will test the hypothesis that HIF1α inhibition induces adaptive resistance via compensatory stabilization of oncogenic protein ID1 in hypoxia, which in turn supports the hypoxic growth of HIF1α-inhibited tumors. We further hypothesize that silencing ID1 or ID1-mediated oncogenic pathways will block the resistance and enhances the antitumor efficacy of HIF1α inhibition. We will use molecular biology and preclinical animal models to test this hypothesis in three specific aims. Aim 1: Determine the role of ID1 in conferring resistance to HIF1α inhibition in vitro and in vivo. Aim 2: Elucidate the mechanism by which ID1 protein is regulated by HIF1α in hypoxia. Aim 3: Determine the mechanism by which ID1 confers resistance to HIF1α inhibition in hypoxia. The successful completion of these aims may deepen our understanding of the role of HIF1α in cancer biology and therapy, may provide a rational approach to the clinical translation of HIF1α-inhibitory agents, and may lead to novel and lifesaving treatments for patients with advanced and metastatic disease.

Public health relevance
Project Narrative HIF1α is a fundamentally important molecular driver of cancer malignancy and mortality. This proposal is aimed at understanding how tumor cells develop adaptive resistance to the therapeutic inhibition of HIF1α. The results of this study promise to provide a mechanism-based and rational approach to the clinical translation of HIF1α-inhibitory agents, and promise to lead to novel and lifesaving treatments for patients with advanced cancer.